NUTRITION OBESITY RESEARCH CENTER

DESCRIPTION (provided by applicant): There presently are 67 Affiliate Investigators (Als) of the NORC (Table 1) representing a diversity of divisions, departments, and schools throughout the University of Washington (UW) system (see Table 2). Although most of the investigators are in clinical departments, the UW is unique in that many of its basic scientists actually have their primary appointments in clinical departments. There has been a longstanding interest in several aspects of nutrition and obesity at the UW. However, over the past several years, Als have tended to focus their research in the following major areas: 1. Body Weight Regulation and Obesity 2. Adipose Tissue Biology and Inflammation 3. Lipids and Atherosclerosis 4. Diabetes

Public health relevance
RELEVANCE (See instructions): Obesity and associated metabolic disorders have emerged as leading health problems in the US and other westernized countries. Compounding this problem is a lack of effective nonsurgical treatments for obesity, which reflects deficiencies in our understanding of underlying causes. The NORC offers valuable resources to a large group of researchers at UW investigating nutrition, obesity and associated disorders.